Research Training in Cell and Molecular Biology

PROJECT SUMMARY
The mission of the UCLA Cell and Molecular Biology (CMB) Training Program, currently in its 46th year, is to
provide essential training for the next generation of PhDs in the developing fields of genomics, proteomics,
systems biology, quantitative and structural biology, stem cell biology, and bioinformatics so that they are poised
for successful careers in the biosciences. In addition, the CMB provides students with operational and
professional skills training in an inclusive, collaborative, and supportive environment. The CMB Training Program
brings together students and faculty from the life sciences and physical sciences who share a common interest
in cellular and molecular biology but whose interactions might otherwise be limited. The 37 faculty that will
participate in the CMB Training Program are drawn from nine departments that span the UCLA School of
Medicine and the UCLA College. These training faculty are passionate about using cutting-edge multidisciplinary
approaches to tackle complex biological questions at the cellular and molecular level. The proximity of research
buildings and university-supported state-of-the-art shared resources, along with the collaborative spirit that
defines biomedical research at UCLA, facilitate cross-discipline interactions and foster interdisciplinary research
studies. This environment provides trainees a unique opportunity to obtain broad foundational training in modern
cell and molecular biology. CMB trainees are drawn from four PhD graduate programs: the Molecular Biology
Interdepartmental Program; Neuroscience; Biochemistry, Molecular & Structural Biology; and Chemistry. Each
year, the CMB Training Program will recruit 12 new students to a two-year program, which will be inclusive of
students from underrepresented groups in the sciences. As part of the CMB training plan, CMB trainees must
take four foundational courses that were designed specifically for training in modern cellular and molecular
biology research. The objectives of these courses are to train students to develop technical, operational, and
professional skills that will prepare them for biomedical careers including: a broad understanding of the cell and
molecular biology field and the pressing questions and modern approaches used to address them; rigorous
experimental design skills; statistical skills for data analysis; analytical and critical thinking skills; oral and written
communication skills; resilience skills; and an understanding of how to conduct safe and ethical research studies.
Through a CMB career development course, trainees are also exposed to broad biomedical careers and acquire
knowledge on how to prepare and apply for these professions. The CMB Training Program also provides
mentoring and structured cohort-building and training activities, like the CMB Luncheon Seminar Series and the
CMB retreat, that engage, support, and retain students in science and promote collaborative studies among
trainees. Together, the CMB Training Program’s student-centered interdisciplinary research training, active
learning curriculum, career-development activities, mentoring, and community-building activities contribute to
the successful training of diverse students for a broad array of biomedical careers.

Public health relevance
PROJECT NARRATIVE The UCLA Cell and Molecular Biology (CMB) Training Program endeavors to train and prepare the next generation of diverse cell and molecular biology PhD students for biomedical careers. The underpinnings of the CMB Training Program come from the interdisciplinary state-of-the-art research training in cellular and molecular biology provided by the CMB student-centered curriculum, structured-activities, and faculty mentors. Additionally, the CMB Training Program provides training in resilience, skill development, and career development, while supporting trainees through mentoring and cohort-building activities.